Role of Rab27b in synucleinopathies

Recent evidence points to αsyn misfolding and cell-to-cell transmission as critical to neurodegeneration in
Parkinson’s Disease (PD) and Dementia with Lewy Bodies (DLB). Key steps implicated in αsyn spread include
release, uptake, misfolding, and impaired protein degradation, yet the key molecular mechanisms that regulate
αsyn spread are poorly understood. Rab proteins are small GTPase proteins that control protein trafficking and
degradation and have been implicated in αsyn pathogenesis. Among the Rab proteins, Rab27b is highly
expressed at synaptic terminals in neurons in key brain areas affected in PD and DLB. Rab27b regulates synaptic
vesicle (SV) exocytosis and recycling. In non-neuronal cells, Rab27b regulates the distal transport of lysosomes.
We recently showed elevated Rab27b levels in αsyn models and in human PD and DLB. Furthermore, we
observed that Rab27b KD increases αsyn toxicity by disrupting autophagic flux - pointing to a protective role for
Rab27b in cells with high intracellular αsyn burden. Surprisingly, the effects of Rab27b were different in the αsyn
fibril model, in which neurons were exposed to extracellular αsyn fibrils: Rab27 KO reduced fibrillary αsyn uptake
to prevent αsyn inclusions and neuronal loss. Based on these data, we hypothesize that Rab27b plays two
critical yet potentially opposing roles in αsyn handling: 1) Rab27b promotes αsyn autophagic-lysosomal
degradation, yet 2) Rab27b can facilitate endocytosis of pathologic, extracellular αsyn as part of its role in SV
recycling. Early in disease, we propose that Rab27b upregulation is neuroprotective: Rab27b aids intracellular
αsyn clearance. Yet, as disease progresses and extracellular αsyn levels increase, Rab27b’s role in SV
endocytosis becomes maladaptive, overcoming any protective function in protein degradation, and aids αsyn
cell-to-cell transmission. Our proposed studies will examine the impact of Rab27b and its interactors on two
critical biological processes implicated in αsyn pathogenesis. In Aim 1, we will test the mechanisms by which
Rab27b promotes clearance of intracellular αsyn, and examine its interactions with other proteins involved in
autophagic-lysosomal function. In Aim 2, we will elucidate the mechanisms by which Rab27b aids αsyn entry
into neurons and determine its interaction with other synaptic trafficking proteins to mediate this effect. In Aim 3,
we will test the overall consequences of Rab27b on αsyn pathology over time in two in vivo αsyn models. A
greater understanding of the network of proteins that shape αsyn transmission will have significant impact on the
development of future therapies for PD and DLB.

Public health relevance
Parkinson's disease (PD) and Dementia with Lewy Bodies (DLB) are progressive neurodegenerative disorders that cause significant motor and cognitive disability with no current therapies that slow disease progression. In this proposal, we will investigate the role of Rab27b in the pathophysiology of these disorders. Our long-term goal is to establish whether Rab27b pathways may serve as therapeutic targets for PD and DLB.